Rochester Roybal Center for Social Ties and Aging Research

Abstract
The mission of the University of Rochester Roybal Center for Social Ties & Aging Research is to advance
development of novel, principle-guided behavioral interventions that promote social connectedness for healthy
aging. We focus on a highly vulnerable population: those who provide care for a family member with
Alzheimer’s disease or related dementia (ADRD). The long-term effects of caregiving on caregivers’ health are
well-established. Caregivers are also vulnerable to social isolation, poor quality relations, and loneliness – i.e.,
social disconnectedness. Social disconnectedness is a critical determinant and indicator of health and well-
being. Yet, among proximal health risks, social connectedness is a gravely understudied target of intervention
that has potential for substantive impact on the health and well-being of caregivers. The University of
Rochester Roybal Center for Social Ties & Aging Research (the STAR Center), will achieve its mission through
leadership and infrastructure that catalyzes multidisciplinary collaborations necessary to efficiently usher social
connectedness intervention development along the continuum of the NIH Stage Model. Specifically, the STAR
Center aims to: provide leadership and coalesce expertise to develop and advance social connectedness
interventions; to stimulate novel clinical research and multidisciplinary collaborations to support development of
mechanism-informed, effective behavioral interventions that promote social connectedness in caregivers of a
family member with dementia; and to provide solid, supportive infrastructure that fosters scientific productivity
among STAR Center investigators to achieve its mission.

Public health relevance
Caring for a family member with Alzheimer’s disease or related dementia (ADRD) can be isolating and lead to loneliness, adding to the constellation of established risk factors that increase the poor health observed among family caregivers. The mission of the University of Rochester Roybal Center for Social Ties & Aging Research is to advance development of novel, principle-guided behavioral interventions that ensure social vitality and well-being for healthy aging in middle aged to older caregivers of a family member with ADRD.